Neural circuits for action perception: An integrative approach

Project summary
Social interactions – a ubiquitous and essential aspect of our everyday life – rely on the correct
perception of the actions of others. Experimental evidence suggests that the ability to interpret
others’ actions is subserved by a network of areas of which motor cortex represents an
important hub. The precise role of this motor hub in action perception is still largely unknown.
In this proposal, we will assess the mechanisms underlying action perception through invasive
recordings of intracranial field potential signals in humans and computational analyses methods.
This approach will allow us to study the role of motor processes in action perception with high
spatiotemporal accuracy.

Public health relevance
Project narrative The correct perception of the actions of others is the cornerstone of our social interactions. The neural substrates of this fundamental skill are still poorly understood. Elucidating the mechanisms underlying action perception will have important implications for mental health disorders characterized by dysfunctional social interactions such as autism. Furthermore, given the present trend toward interactions with embodied artificial agents, biological insights about action perception will also inform the design of future human-robot interaction paradigms. Here we will examine the neural circuits responsible for action perception through invasive neurophysiological recordings in humans.